Infarct-related Ventricular Tachycardia Mechanisms: From Micro to Clinical

PROJECT SUMMARY
Ventricular tachycardia (VT), a life-threatening fast heart rhythm, occurs frequently in patients with myocardial
infarction, leading to sudden cardiac death. Catheter-based ablation offers the possibility of permanent cure
by interrupting the VT reentrant circuit. Unfortunately, eliminating infarct-related VT with ablation has achieved
only modest success, 50-88%. This stems from limitations associated with the current VT electrical mapping
and the use of the clinical VT maps to identify the target locations for ablation. Employing new strategies that
provide comprehensive understanding of the complex phenomena in the zone of infarct, and how they correlate
to clinical measures is a quest of paramount clinical signiﬁcance, as will lead to a signiﬁcant improvement in the
identiﬁcation of optimal ablation targets for infarct-related VT.
The overall objective of this project is to apply novel imaging and modeling methodologies to provide
a comprehensive understanding of the complex micro-structural and electrophysiological (EP) factors
that establish speciﬁc VT pathways in the zone of the healed infarct and to determine how these factors
are reﬂected in clinical imaging and EP measurements. Our ability to achieve this objective stems from new
developments by our team, such as the invention of a new MRI pulse sequence that allows us to acquire non-
destructively images of entire human and large animal hearts ex-vivo at previously unattainable (sub-millimeter)
resolution. We will use our new sub-millimeter imaging capability to acquire contrast-enhanced and diffusion-
tensor MRI of swine and human hearts ex-vivo and develop individualized models from these images. These
high resolution ex-vivo models will be used to test a number of novel mechanistic hypotheses elucidating how
the complex spatially-distributed structural and EP characteristics of the healed infarct establish preferential VT
pathways through it. We will then conduct simulation and experimental research to establish the relationship
between the infarct structural and EP characteristics at the sub-millimeter scale that give rise to speciﬁc VT
pathways, and the image features and electrical signatures in corresponding clinical-resolution measurements.
Successful execution of the proposed studies will provide a new understanding of the signatures of the com-
plex infarct-related micro-structural and EP remodeling as they are manifested in clinical measurements. The new
insight will enable improved determination of the optimal ablation option for a given VT, leading to a signiﬁcant
advancement in the efﬁcacy of the therapy.

Public health relevance
PROJECT NARRATIVE Ventricular tachycardia, a life-threatening fast heart rhythm, occurs frequently in patients with myocardial infarction, leading to sudden cardiac death. Understanding of the complex phenomena in the zone of infarct and how they correlate to clinical measures is a quest of paramount clinical signiﬁcance. The overall objective of this project is to apply novel imaging and modeling methodologies to provide a comprehensive understanding of the complex structural and electrophysiological factors that establish speciﬁc ventricular tachycardia pathways in the zone of the healed infarct and to determine how these factors are reﬂected in clinical imaging and measurements.